Molecular functions of Tcf-1 in DP thymocytes

PROJECT SUMMARY
Thymic development is highly responsible for shaping a healthy and balanced T cell immunity. Like other
developmental processes it involves coordinated changes in the linear and three-dimensional chromatin
organization that allow stage specific transcription events. A central regulator at nearly every stage of T cell
differentiation is the DNA binding protein Tcf-1. Studies proposed here will elucidate how Tcf-1 coordinates the
action of epigenetic and transcription regulators to instruct the differentiation of CD4+CD8+ DP thymocytes. Tcf-
1 modulates the chromatin landscapes and transcription profiles directly through binding to its conserved DNA
sequence, or indirectly in association with other regulatory proteins. DP thymocytes express two forms of Tcf-
1, the full length Tcf-1p45 protein that binds β-catenin, and a short Tcf-1p38 isoform that does not. Lef-1, another
member of the Tcf/Lef family of regulators, also expressed in thymocytes has overlapping functions with Tcf-1.
In addition Tcf-1 cooperates with the HLH domain DNA binding protein HEB at the DP thymocyte stages
through the sharing of ~7000 DNA binding sites genome wide. The presence of both Tcf-1 and HEB at the
shared sites is necessary to promote chromatin accessibility and regulate gene transcription. The direct Tcf-1-
HEB binding to their conserved motifs in enhancer regions of T cell differentiation genes promotes their
expression. By contrast Tcf-1-HEB recruitment to sites lacking conserved motifs, in promoter regions of cell-
cycle genes reduces their expression and cell proliferation. Such opposing transcription outcomes likely involve
Tcf-1-HEB recruitment to DNA in the context of distinct regulatory complexes. The composition of complexes
containing Tcf-1 and HEB, the specific Tcf-1 isoform involved in each complex, and which functions are
redundant between Tcf-1 and Lef-1, still remain to be elucidated. The intricate functional co-operation between
these factors likely also involves the ability of Tcf-1 and Lef-1 to bend the DNA helix at their binding site which
may modulate the 3D chromatin conformation, and define the proximity between co-operating factors and
regulatory elements. These findings and the existing literature provide strong premise for the hypothesis that
DP thymocyte development is enabled by the cooperation of Tcf-1 isoforms with protein complexes that shape
the 3D chromatin structure to differentially regulate gene expression. Two specific aims are proposed. Aim 1
will determine the how Tcf-1p45 and, Tcf-1p33, co-operate with Lef-1 and HEB in the context of distinct regulatory
complexes to establish the epigenetic and transcription profile of DP thymocytes and control their
developmental progression. Aim 2: will elucidate the roles of Tcf-1p45, Tcf-1p33, Lef-1 with HEB shaping the
chromatin conformation, and how this function promotes DP thymocyte development. The proposed studies
are expected to highlight a completely new layer in the molecular regulation of DP thymocytes.

Public health relevance
PROJECT NARRATIVE Nearly every stage of T cell development critically depend on Tcf-1, a multifunctional protein, expressed in distinct isoforms, that regulates of the chromatin landscape, conformation and gene expression. The proposed studies will address the hypothesis that Tcf-1 participates in distinct regulatory protein complexes and cooperates with Lef-1 and HEB to dynamically modulate chromatin conformation and expression profiles that guide thymocyte development. Determining how these regulators co-ordinate to establish epigenetic and chromatin conformation states will provide a novel and comprehensive molecular model of how DP thymocyte programs are modulated.